Molecular mechanisms of eukaryotic translational control

SUMMARY:
The level of each protein synthesized in a cell results from both the amount of mRNA available, and
the number of ribosomes that initiate translation of that mRNA. Eukaryotic translation initiation factors
(eIFs) can reprogram which mRNAs are available and translated to produce different levels of the
encoded proteins in response to discrete cellular signals. In fungal species, translational control plays
important roles in host evasion and other pathogenesis mechanisms, and in mammalian species,
altered levels and modifications of eIFs influence cancer progression and other disease states. A
number of protein factors stimulate translation, including the eIF4 factors (4A, B, E, G, and H) that
engage the 5’ cap of mRNA and the small subunit of the ribosome, to promote events prior to start
site recognition. Ample data support roles of the RNA helicase 4A and cofactors 4B and 4G in
unwinding 5’ UTRs to promote translation of structured mRNAs. However, the mRNAs that depend
on 4B activity for translation are distinct from those that rely heavily on 4G, even though both factors
promote 4A activity. Moreover, in striking contrast to protumorigenic 4A and 4G, increased levels of
4B improved survival of patients with aggressive cancers, and preliminary data directly implicated 4B
in opposing metastasis of murine breast cancers. Understanding how 4B mediates translation of
specific transcripts could be important for understanding and predicting metastatic phenotypes.
Finally, posttranslational modifications of the eIF4 factors are known to modulate translation in
mammals, and deregulation is common in disease states. However, it is unclear how modifications of
the eIF4 factors regulate translation in fungal species and how this affects expression of specific
mRNA pools. This proposal takes on these challenges, investing years of experience characterizing
the mechanics of yeast translation initiation and a powerful arsenal of in vitro, genetic, and genome-
wide tools. In order to better understand how mRNAs are selected by ribosomes for translation, the
objective of this work is to understand how 4B achieves translation versus repression of
specific mRNA pools in yeast. Three aims will be pursued: Aim 1. Determine how 4F and 4B
interactions affect translation of 4B hyper and hypo-dependent mRNAs. Aim 2. Elucidate yeast 4B-
RNA binding preferences. Aim 3. Understand how posttranslational modifications (PTMs) of 4F and
4B impact 4B-specific mRNA control. This proposal will use eIF4B as a model to determine how core
translation initiation factors modulate translation versus repression of specific mRNA pools and will
shed light on how robust activity of 4B opposes the metastatic phenotype.

Public health relevance
Narrative: The protein synthesis machinery has long been recognized as a therapeutic target of vast potential. The eukaryotic translation initiation factor 4B promotes a protein synthesis program that opposes both metastatic behavior in cancers and activity of other initiation factors in cells; hence, our work determining mechanisms by which eIF4B operates and is regulated could open new avenues for early detection and treatment of cancer and other diseases.